Non-invasive Brain Sodium Quantification in Multiple Sclerosis

? DESCRIPTION (provided by applicant): Multiple sclerosis (MS) is a chronic inflammatory-demyelinating and neurodegenerative disease of the central nervous system that affects 400.000 people in US. While it only slightly shortens life expectancy, MS is the leading cause of non-traumatic neurological disability in young adults. There is ever-growing evidence that neuro-axonal degeneration is the main pathological correlate of clinical disability. Despite its clinical relevance little is known about the mechanisms leading to axonal degeneration due to the lack of methods for exact identification and quantification of neurodegeneration in vivo and due to the paucity of neuropathological data. It has been suggested that the accumulation of intra-axonal sodium ions represents a key factor in the degenerative process and that partial blockade of sodium channels protects axons from degeneration in experimental models of MS. Changes in the intracellular sodium content (ISC) lead to changes in the total tissue sodium concentration (TSC) that can be measured in vivo by single quantum Sodium MR Imaging (23Na MRI). The application of triple quantum sodium filtration, allows an improvement in the specificity of TSC by measuring ISC and neglecting most of the signal contributions from the extra-cellular sodium content. Therefore, we propose that (1) excess intracellular sodium plays an important role in neuro-axonal injury in MS contributing to brain volume loss~ (2) changes in brain total sodium concentration (TSC) as well as in ISC can be measured in vivo with single and triple quantum 23Na MRI~ (3) sodium-related brain tissue damage is a critical element in the accumulation of disability. Initially, we will measure at ultra-high field MRI and compare brai TSC and ISC values in MS patients with different clinical course and healthy controls. Then, we will correlate 23Na MRI metrics with conventional MRI measure of tissue damage, neurological and cognitive impairment. Finally, we will examine whether group differences in brain volume and clinical outcomes can be explained by differences in TSC and ISC. This research is innovative because it uses a newly developed cutting-edge technology to discover the mechanisms that bridge the gap from inflammation to irreversible disability in MS. The proposed research is significant because it will advance our understanding of the pathophysiology of neurodegeneration in MS, and will help identify potential novel outcome measures of disease progression, thus improving the clinical management of patients with MS.

Public health relevance
PUBLIC HEALTH RELEVANCE: The health relatedness of this project: (i) In vivo sodium imaging will improve our understanding of pathologic factors that underpin disease progression and will provide new metrics for assessment of disease progression and clinical outcome. (ii) The MR methodologies utilized in this proposal could provide more specific and sensitive tools to detect and understand the beneficial effects of new treatments